Delivery of Biological Therapeutics: Using Engineered Particles and Novel Deliver

DESCRIPTION Abstract Getting promising biological therapeutics to the desired location in the body in a safe and effective fashion is one of the key challenges in medicine. Many different disease states are now being targeted for treatment with biologicals including oncology, autoimmune, inflammatory, metabolic, cardiovascular, neurological, and ophthalmologic. In addition, it is anticipated that biological therapies will play a major role in the treatment of pain and for the use in anti-infective, anti-bacterial, anti-viral and anti-fungal treatments. However, despite the opportunity, there are significant road blocks that stand in the way to realizing the full potential of biological therapeutics and vaccines including: i) the need to dramatically improve circulation times;ii) the inability to tailor pharmacokinetics using simple injections or oral delivery;iii) the inability to deliver biologicals via pulmonary routes;iv) the inability of many biologicals to access intracellular targets;and v) the inability to deliver biologicals to poorly-vascularized tissues. Herein I propose to evolve emerging top-down particle fabrication technologies to make 2-dimensional arrays and free flowing powders of shape specific micro- and nano-particles that are comprised of almost pure biological molecules. Using patterned thin film based lyophilization processes that have very high rates of thermal and mass transport, "solid state solutions" of particles comprised of biological molecules will be synthesized to control how quickly the molded particles will dissolve or how quickly the biological molecules within the particles will be released. In addition, I propose to exploit the unique 2-dimensional array format and the formation of free flowing powders of shape controlled biological therapeutics and vaccines to develop three novel dosage forms including: i) delivery via highly concentrated dispersions (alternative to solutions);ii) pulmonary delivery via inhalation;and iii) novel endosco

Public health relevance
Public Health Relevance Statement Many different disease states are now being considered for treatment with biological therapeutics including oncology, autoimmune, inflammatory, metabolic, cardiovascular, ophthalmology and numerous infectious diseases. It is anticipated that many of the new developments in the treatment of neurological disorders (e.g. Parkinson’s diseases) will be based on biological therapies, as will the treatment of pain. Adult and pediatric vaccines are all based on the effective delivery of biological molecules. Monoclonal antibodies (mAbs), antibody fragments and peptides are being considered for numerous emerging antiinfective, anti-bacterial, anti-viral and anti-fungal treatments. My proposal for the NIH Director’s Pioneer Award will focus on realizing the full potential of biological therapeutics and vaccines through the development of innovative delivery approaches for getting promising biological therapeutics and vaccines to the desired location in the body in a safe, cost-effective and reliable fashion. Delivery methods are needed that can: i) dramatically improve the circulation times of biologicals; ii) allow one to tailor the pharmacokinetics of biological therapeutics and vaccines using simple injections or oral delivery; iii) deliver biologicals via pulmonary routes; iv) deliver biological therapeutics to intracellular targets; and v) deliver biological therapeutics to poorly-vascularized tissues and cells.